Immune checkpoint Inhibitor-Induced Autoimmune Diabetes: Immunological Mechanisms and Biomarker Discovery in Provoked Beta Cell Autoimmunity

Project Summary/Abstract
Within the last decade, immune checkpoint inhibitors (CPIs) have changed the landscape of cancer care, but
also heightened risk for a range of endocrinopathies. While CPI treatment has led to tremendous benefits in a
subset of cancers, they also have led to new-onset autoimmune disease (also known as “immune related
adverse events” or “irAEs”) that can involve almost every organ. Within endocrine organs, insulin dependent
autoimmune diabetes (CPI-DM) is highly morbid and potentially lethal. With this proposal Dr. Quandt plans a
multipronged approach to address the mechanistic understandings of CPI-DM as examples of provoked
autoimmunity. In Aim 1, Dr. Quandt will address genetic predisposition to CPI-DM. In Aim 2, Dr. Quandt will
use an unbiased high throughput assay for novel autoantigen discovery to elucidate the specificity of the
immune response in CPI-DM. In Aim 3, Dr. Quandt will use single cell methodologies to identify cellular
phenotypes, activation, and differential gene expression contributing to a transcriptional signature critical to
CPI-DM development. These studies will contribute to mechanistic understanding of CPI-DM with hope that
they may lead to identification of actionable targets that could be used in the prevention or treatment of type 1
diabetes mellitus (T1DM), both in the setting of cancer immunotherapy and conventional disease.
Dr. Quandt’s goal is to become a translational physician-scientist specializing in the immunology of T1DM and
endocrine related aspects of cancer care, including endocrine irAEs. Bridging the divide between patient care
and bench science is critical to furthering medical knowledge in both these novel and well-established
autoimmune diseases. Dr. Quandt will advance her current experience in endocrinology, epidemiology and
biostatistics through further training in wet lab approaches and bioinformatics including genetic analysis and
computational immunology. This experience will anchor her understanding of translational methods to match
her clinical research expertise. Her team of mentors, scientific advisors and collaborators are leaders in their
respective fields. This training plan and scientific team will be coupled with the exceptional environment
provided by the University of California, San Francisco, ensuring that Dr. Quandt will successfully advance to
meet her career goal and transition to independence.

Public health relevance
Project Narrative Immune checkpoint inhibitor (CPI) induced diabetes (CPI-DM), a rare but highly morbid endocrine immune related adverse event (irAE), offers a unique opportunity to study beta-cell autoimmune disease. Identifying genetic risk and immune features of CPI-DM will advance possible prediction and intervention for prevention and treatment of CPI-DM, thereby furthering cancer care. Furthermore, these findings will illuminate steps required for autoimmune destruction of beta-cells occuring in type 1 diabetes mellitus (T1DM).